AEC Conference Support 5 year

Project Summary/Abstract
The National Environmental Health Association (NEHA), a 501(c)3 nonprofit organization, is pleased
to submit an application for funding assistance under the U.S. Food and Drug Administration (FDA)
Support for Conferences and Scientific Meetings (R13 Clinical Trial Not Allowed), FOA Number: PAR-
19-306.
The NEHA Annual Educational Conference (AEC) & Exhibition was first held on June 25, 1937, and
there have since been 85 AECs convened in North America, including Hawaii, Alaska, Rhode Island,
and Canada. The AEC is designed to train, educate, and advance environmental health professionals
by providing the means to build a network of colleagues, exchange information, and discover new, best,
and practical solutions to food safety and other environmental health issues. The AEC brings together
over 1,400 state, local, tribal, territorial, and federal environmental health and public health
professionals from health and environmental protection agencies, as well as from the private sector,
academia, the uniformed services, and international jurisdictions. The AEC provides a means to
translate field-based research into action on retail food safety, program standards conformance,
foodborne outbreak prevention, data and technology, emergency preparedness, and much more. Like
many others, NEHA transitioned to a hybrid format in recent years out of necessity, yet we have
continued the virtual component because of our commitment to small, rural and frontier environmental
health programs that are otherwise unable to travel.
The vision of the Office of Regulatory Affairs within FDA is that “all food is safe…and the public health
is advanced and protected,” as well as its mission to protect consumers and enhance public health by
maximizing compliance and minimizing risk, aligns with our mission to build, sustain, and empower an
effective environmental health workforce. Both missions are embodied in the AEC.
We request funding assistance to develop, administer, and conduct the AEC. NEHA anticipates an
annual estimated cost of $750,000–$850,000 per year over the next 5 years and requests funding to
off-set the virtual platform and audio/visual costs necessary to provide high-quality education to meet
the current and evolving needs of environmental health professionals who can attend in person and
those participating remotely.

Public health relevance
Project Narrative Environmental health professionals are responsible for expertise in a variety of subject matter areas ranging from food safety and retail program standards to emergency preparedness and response and water quality. The AEC aims to provide the most relevant in-person education and the means to connect and engage with peers to build capacity for their organizations and meet the changing needs of the communities they serve. Each AEC highlights how local agencies, industries, and levels of government work to ensure the safety of the public and environment, and how they contribute to the advancement of the environmental health profession.